Characterization of an RNA binding protein required for influenza virus replication

PROJECT SUMMARY/ABSTRACT
The overarching goal of this application is to define and investigate host factors required for influenza virus
replication. Despite current interventions, influenza viruses are responsible for a significant portion of upper
respiratory infections globally. This has prompted exploration of how these viruses interact with host cells to
facilitate their replication. We conducted a series of genome-wide CRISPR screens with nine genetically
divergent influenza viral strains to explore shared host-dependency factors. We identified one such host factor,
TTC14, an uncharacterized RNA binding protein completely required for the replication of all influenza virus
strains. The studies proposed in this application will provide important insights into the role this protein plays in
regulating RNA processing and how its absence impacts influenza virus infection. The goals of this application
are premised on the central hypothesis that TTC14 binds to transcripts and coordinates RNA splicing, leading to
proper downstream protein translation. In Aim 1, I will investigate the molecular mechanism of TTC14-regulated
mRNA splicing in the absence of and during influenza infection. In Aim 2, I will characterize how the loss of
TTC14 expression impacts influenza virus replication in primary human airway cells and how this alters host
immune responses against viral infection. Notably, this research will illuminate a novel regulatory mechanism of
RNA splicing and reveal a new interface between influenza virus and host machinery that many strains
manipulate to aid their replication. Given the extensive expertise of my lab in studying host factors involved in
viral replication, I am uniquely positioned to perform these studies, which will provide new paradigms in
characterizing the complex host-viral interactions of influenza viruses.

Public health relevance
PROJECT NARRATIVE Influenza remains a significant threat to human health despite current interventions; new investigation into virus/host interactions is therefore required to identify potential targets for novel therapeutic interventions. Using unbiased genome wide screening approaches, we have identified a previously uncharacterized cellular protein, TTC14, as a factor essential for all strains of influenza virus replication. The proposed studies aim to understand the cellular functions of TTC14 and define why it is required for influenza virus infection.